Development of the EdvoReader: a Quantitative PCR and Colorimetry Instrument for Laboratory Skills Training

Project Summary
The modern world needs a workforce capable of collecting data, understanding quantitative analysis, and
using that knowledge to make informed decisions. These skills play a role in many careers, including those in
science, but are also vital in navigating daily life. Students gain proficiency in these techniques through
education in science, technology, engineering, and math (or STEM). Despite this push, and over $200 million
per year in funding from the U.S. Department of Education, high school and undergraduate instructors struggle
to incorporate quantitative concepts into their curriculum. Teachers face multiple barriers to success, including
a lack of resources, equipment, expertise, and time. This proposal addresses these deficiencies through the
creation of equipment and experiments that bring quantitative research to the teaching laboratory.
The instrumentation needed for quantitative experiments is often too expensive, bulky, fragile, or complicated
for use in an educational environment. Therefore, we aim to develop a simple new device that allows students
to explore a large array of quantitative biology techniques in the lab. This device, called the “EdvoReader”, will
be designed using recent advances in LED and optical detection electronics. The EdvoReader will be designed
specifically for educational use and will be capable of both colorimetry and real-time PCR analysis, exposing
students to a range of diverse biological measurements. Importantly, by building this instrument from the
ground up, the EdvoReader can incorporate the features most requested by educators while minimizing costs.
The instrument will be validated using existing assays and compared to current equipment to ensure that it is
capable of reproducible measurements.
During Phase I a collection of robust, classroom safe experiments will be adapted from authentic EPA water
quality testing for bacteria, iron, and lead contamination. These assays are used worldwide for environmental
monitoring, allowing us to validate the equipment using known standards and lay the groundwork for the
commercialization of the EdvoReader platform. Without the EdvoReader these real-world quantitative
experiments would require multiple expensive pieces of equipment. Importantly, the experiments have broad
appeal, making them ideal for biotechnology, biology, and environmental science classes.
An advisory board of high school teachers, university instructors, and non-profit educators has been recruited
to support the development of the EdvoReader and a citizen science curriculum. This will guide our work with
students, which will begin in Phase II. By combining a classroom-focused instrument with dedicated
experiments, the EdvoReader platform will provide educators with an inexpensive and accessible pathway to
instruct cutting-edge biotechnology. In turn, students will gain valuable hands-on training in real-world, relevant
quantitative techniques and an understanding of STEM analysis that is underutilized in classroom laboratories.

Public health relevance
Project Narrative The development of quantitative skills in the high school and college biology laboratory, through the use of statistics and mathematics to analyze experimental results, is critical for student success and the establishment of 21st-Century STEM Skills. Unfortunately, the integration of quantitative biology into existing curricula using techniques like qPCR and colorimetry can be difficult due to the complexity of experiments and the expense of available laboratory instruments. In this grant, we propose the creation of an inexpensive, user-friendly instrument, the EdvoReader, and easy to implement citizen science experiments that will allow students to conduct hands-on quantitative biotechnology assays in the teaching laboratory.